Characterizing excitatory synapse in vivo structural dynamics

Many brain disorders manifest impaired synaptic integrity, stability, and experience-dependent selection,
resulting in wiring deficits and perturbed function. Unfortunately, our ability to monitor synaptic or circuit failures
as they occur has been hindered by the difficulty of visualizing synapses in vivo. Here we propose in vivo
monitoring of the ‘order of operations’ in excitatory synapse formation and elimination, and identifying the steps
and molecules controlling experience-dependent synapse selection. We focus on the visual system, where there
is a well-characterized toolkit for manipulating experience. We hypothesize that the dynamics of a synapse's
assembly and disassembly, and its propensity to remodel, are intimately linked to its connection identity and
proteomic content. To test this, we propose the following aims: Aim1: To track the structural remodeling of
excitatory synapses and how it relates to their afferent input specificity and proteomic content. We will
label LGN or LP thalamic inputs onto the full dendritic arbor of single L2/3 pyramidal neurons in mouse visual
cortex, track their daily dynamics and their response to visual deprivation, and analyze their proteomic content
in relation to dynamic history and afferent identity. To this purpose, we will implement triple color two-photon
microscopy to simultaneously track, in vivo, both pre- and postsynaptic elements of excitatory synapses, followed
by Magnified Analysis of Proteome (MAP), a combination of tissue clearing and expansion microscopy, for super
resolution analysis of synaptic protein content across the entire neuron. Aim 2: To dissect, at a molecular
level, experience-dependent selection and stabilization of excitatory synapses. CPG15/neuritin is an
activity-regulated gene product critical for synapse stabilization and maturation. In vivo imaging in WT and
CPG15 knockout mice revealed that while spine formation occurs normally in the absence of visual experience
or CPG15, in both cases PSD95 recruitment to nascent spines is deficient. CPG15 expression in the absence
of activity is sufficient to restore normal PSD95 recruitment and spine stabilization, suggesting it acts as an
activity-dependent synapse selector. A puzzling aspect in this scenario is that CPG15 is extracellular while
PSD95 is intracellular, and neither has a transmembrane domain. Interestingly, CPG15 was previously identified
as part of the AMPA-type glutamate receptor (AMPAR) proteome. Yet, CPG15's mechanism of action remains
unclear. To probe CPG15's synaptic function, we will map the minimal CPG15 binding domain on the AMPAR,
and test whether preventing its interaction with CPG15 effects AMPAR interaction with stargazin, an adaptor
molecule that is essential for delivering, inserting, and retaining functional receptors at the PSD. To probe how
CPG15 binding influences AMPAR stability at the synapse and how this, in turn, effects synaptic presence of its
downstream interacting proteins, stargazin and PSD95, we will develop an in vitro assay for synaptic AMPAR
mobility. Finally, we will ask how loss of CPG15, as a surrogate of experience, impacts the molecular sequence
of synapse formation, stabilization, and maturation in vivo, using two photon microscopy followed by MAP.

Public health relevance
It is thought that many neurodevelopmental and neurodegenerative disorders, including ones that effect visual perception, lead to disruptions in synaptic integrity and stability, resulting in wiring deficits and perturbed brain function. We understand little regarding how disruptions in synapse formation and circuit connectivity arise, largely due to paucity of methods to visualize such events as they occur in vivo. In this proposal we combine innovative in vivo imaging technology and labeling methods with classical visual manipulations to establish a baseline characterization of the molecular events in excitatory synapse formation and stabilization, and investigate how the proteomic content of a synapse reflects its circuit identity, dynamic lifetime, and propensity for plasticity.